Elucidating the complex allosteric regulation of PFK-1, a broadly evolutionarily conserved glycolytic enzyme

PROJECT SUMMARY/ABSTRACT
Allosteric enzymes govern many metabolic and regulatory processes. Their regulation is modulated by the
binding of an effector molecule to a site distal to their active site, inducing a conformational change that alters
their activity. As such, the dysregulation of allosteric enzymes can cause metabolic disorders and
cancer. However, despite its importance and ubiquity in biological processes, general mechanisms for protein
allostery are poorly understood, and no single approach typically provides sufficient structural and energetic
information to describe allosteric conformational changes in full molecular detail for most enzymes.
Phosphofructokinase-1 (PFK-1) is a broadly conserved, allosterically regulated glycolytic enzyme. PFK-1
effectors elicit subtle conformational changes in the protein’s ensemble and oligomer state that
modulate its activity. Cancer-associated somatic mutations in PFK-1 have been identified across the length of
protein and in a wide range of cancer types. Altered PFK-1 allostery from somatic mutations and post
translational-modifications has been shown to play a role in metabolic re-programming in cancer, making PFK-
1 an attractive therapeutic target. However, due to human PFK-1’s (hPFK) complex combinatorial regulation by
~20 effectors, for which few binding sites are known, structural data are insufficient for understanding shifts in
hPFK’s conformational ensemble upon allosteric effector binding. This complex combinatorial regulation cannot
be explained by a simple phenomenological model of allostery. A deeper understanding of hPFK’s ensemble
regulation is necessary to determine how disease-associated mutations disrupt its allostery to drive disease
phenotypes. A complete picture of the mechanism and evolution of combinatorial ligand regulation in hPFK will
enable the rational design of allosteric therapeutics to specifically target this and other conserved, essential
enzymes traditionally considered to be “undruggable”.
In this proposal, I will train in multidisciplinary techniques, combining computational protein design, molecular
dynamics (MD) simulations, traditional biochemistry, and hydrogen-deuterium exchange with mass
spectrometry (HDX/MS) to 1) discover the molecular basis for allosteric ligand regulation in hPFK, 2) map the
evolution of allosteric ligand regulation in PFK-1 from prokaryotes to eukaryotes, and 3) design a peptide
antibiotic that specifically inhibits multidrug-resistant (MDR) E. coli PFK-1. Our approach to discover the
molecular details of PFK-1 effector regulation will enable future discoveries of how long-range allostery is
encoded in other oligomeric enzymes. This work will deepen our understanding of the role of allosteric
conformational changes to tune protein function in healthy and disease states.

Public health relevance
PROJECT NARRATIVE Allosteric regulation of enzymes, which underpins many metabolic processes, can be perturbed by genetic mutations, contributing to metabolic re-programming in cancer and other diseases. The broadly evolutionarily conserved enzyme phosphofructokinase-1 (PFK-1) is allosterically regulated by many small molecules to control glycolytic flux in the cell, but the evolution and molecular mechanism of this regulation is poorly understood. We propose to characterize the complex combinatorial allosteric mechanism of PFK-1 towards the rational design of powerful therapeutics to target this essential enzyme in metabolic diseases and cancer.